Short Term Variability in Affect and Rest Activity Rhythms in Long Term Chronic and Highly Variable Suicidal Ideation in Depressed Older Adults

ABSTRACT
Our ongoing research (R01 MH085651) aims to identify long-term suicide risk factors in older depressed adults. In this
supplement, we propose to study a new line of research focusing on how proximal risk factors, such as severity and
fluctuation of affect, inter-daily stability of the 24-hour rest-activity rhythm, and sleep health relate to suicide risk in
depressed older adults. Poor sleep health and disruption of the 24-hour rest-activity rhythm (RAR) are linked to
numerous indices of morbidity and mortality in older adults, including suicidal ideation. Affect dysregulation is also
linked to contemplation of suicide and suicidal behavior in younger age groups. While there are complex, bi-directional
relationships between suicide risk, sleep/activity, and mood, these relationships have yet to be measured using
actigraphy and digital monitoring in well-defined suicide risk groups. We propose an Administrative Supplement for a 3-
week pilot study measuring daily affect and rest-activity rhythms (via digital monitoring and actigraphy) to provide a
real-time assessment of potential suicide risk factors so far unevaluated in the parent study. Data on participants’ clinical
and cognitive characterization, including suicidal ideation trajectories, will be provided by the parent study. Participants
will be aged 60 years and older, enrolled in the parent grant, and have met criteria for unipolar major depressive
episode. Building on our data that indicated that both chronic severe and highly variable ideators had a higher risk of
suicidal behavior than low/non-ideators, groups will include two high suicide risk groups (chronic severe ideators: N=20,
highly variable ideators: N=20) and one low suicide risk group (no/minimal ideation: N=20). Affect ratings and digital
sleep diaries will be collected twice daily over 3 consecutive weeks, and RAR metrics (using objective activity count
patterns) will be collected during the same period, with interdaily stability as the primary RAR measure. The proposed
research aligns with RDoC category of Arousal/Regulatory Systems including constructs such as Circadian Rhythms and
Sleep/Wakefulness. We build on the complementary expertise of our research team: Dr. Szanto (late-life suicide,
prevention and intervention studies with high suicide risk groups), Dr. Franzen (circadian rhythms and sleep and their
relationship to suicide risk in adolescents and young adults), Dr. Stahl (digital monitoring, geriatric depression,
intervention development to improve circadian rhythmicity and sleep), Dr. Galfalvy (analyses of suicide data, including
digital monitoring and time series data), and Dr. Gujral (geriatric depression and physical activity). The proposed work
complements our current work on long-term suicide risk factors by identifying modifiable proximal behavioral risk
factors that can be used to improve suicide prevention.

Public health relevance
PROJECT NARRATIVE Our previous research has shown that those with severe-persistent and high-fluctuating suicide ideation are at increased risk for death by suicide and suicide attempt. Using actigraphy and digital monitoring, we will investigate how severity and fluctuation of affect, inter-daily stability of the 24-hour rest-activity rhythm, and sleep health relate to suicide risk in these two high suicide risk groups.